Mechanisms regulating fetal membrane and neutrophil responses to infection

Summary/Abstract
Chorioamnionitis - inflammation of the fetal membranes (FM) - is characterized by neutrophil infiltration and is
a major risk factor for preterm birth. Even in the absence of prematurity, chorioamnionitis can be detrimental to
the fetus. Despite a strong association between bacterial infection, chorioamnionitis, and preterm birth, the
mechanisms involved are not fully understood. Through expression of the innate immune pattern recognition
receptors (PRR), Toll-like receptors (TLRs) and Nod-like receptors (NLRs), FMs have strategies to evade and
protect against infection. However, depending upon the nature of signaling and regulation, these protective
immune mechanisms may create an inflammatory milieu that can contribute to pathology. In particular, IL-8 is a
major neutrophil chemoattractant and inflammasome-mediated IL-1b is a major inducer of tissue injury and
mediator of preterm birth. We have found that the chorionic compartment is the primary site of FM IL-8 and IL-
1b production in response to bacterial lipopolysaccharide (LPS), peptidoglycan (PDG), and muramyl dipeptide
(MDP) which activate TLR4, TLR2, and Nod2, respectively. While TLRs and NLRs can directly activate
signaling pathways leading to inflammatory cytokine/chemokine production, there is the potential for far more
complex modulation, regulation, and fine-tuning of these processes and the type of responses generated,
particularly for IL-1b. This grant focusses on the requirement of two or more PRRs to be activated sequentially
in FMs exposed to bacterial triggers via novel intermediates. A non-classical family of microRNAs (miRs)
activate the ssRNA sensors, TLR7 and TLR8, to elicit an inflammatory response. These miRs can also be
carried in exosomes and delivered to TLR7 or TLR8 in target cells. Our preliminary data supports the concept
that TLR8-activating miR-146a-3p may acts as a novel intermediate signal that drives FM chemotactic and
inflammatory responses to bacterial TLR and NLR agonists. We also have preliminary data demonstrating that
FM-derived exosomes containing TLR8-activating miRs trigger neutrophil activation and release of neutrophil
extracellular traps. Finally, we found that FM tissue and circulating exosomal TLR8-activating miR-146a-3p is
elevated in women with preterm birth. Based on this, our central hypothesis is that TLR8-activating miRs
mediate FM chemotactic IL-8 and inflammasome-mediated inflammatory IL-1b in response to bacterial
triggers, and through their release and delivery via exosomes active maternal neutrophils. This leads
to inflammation at the maternal-fetal interface, increasing the risk for chorioamnionitis. To test this, our
specific aims are to determine if:
Aim 1. TLR8-activating miRs mediate a FM chemotactic IL-8 response after exposure to bacterial triggers.
Aim 2. TLR8-activating miRs contribute to FM inflammasome activation and inflammatory IL-1b production.
Aim 3. FM exosomes containing TLR8-activating miRs induce neutrophil activation.

Public health relevance
Narrative The major objective of this proposal is to understand the role that Toll-like receptor 8-activating microRNAs play in mediating fetal membrane inflammation in response to infection, and their role in mediating FM- neutrophil communication through exosome delivery. Our studies will advance our understanding of the mechanisms by which infections cause pregnancy complications, such as chorioamnionitis and preterm birth. Our outcomes have the potential of defining new mechanisms of pathology, predictors of prematurity, and therapeutic targets.